Early Onset Parkinson’s disease subtypes and pathogenic mechanisms

ABSTRACT
Parkinson’s disease is an umbrella of different subtypes that manifest with distinct clinical features and different
underlying pathogenic mechanisms. Genetics, inflammation, and accumulation of alpha-synuclein are the main
pathogenic drivers of the disease, playing a different role in sub-groups of patients. Stratifying patients based on
the main pathogenic mechanisms is becoming key in the scenario of precision medicine. Extensive
characterization of the role of these pathogenic mechanisms in early onset Parkinson’s disease (EOPD) is
lacking. EOPD is a rare condition where PD manifests in patients before the age of 50 years and thus affecting
large part of the lives of these subjects. Our central hypothesis is that EOPD implies different sub-types of
patients with prognostic outcomes related to diverse contribution of genetics, inflammation and alpha-synuclein
accumulation in their pathogenesis. The overall objective of this proposal will be to characterize the contribution
of genetics, inflammation, and alpha-synuclein accumulation in large cohort of EOPD and assess how these
mechanisms can guide the identification of EOPD sub-types. To achieve this objective the main aims of this
proposal will focus on 1) characterizing the clinical and genetic profile of a large cohort of EOPD; 2) assessing
the presence of alpha-synuclein in central and peripheral biosamples; 3) profiling the central and peripheral
inflammatory activation of EODP compared to late onset PD (LOPD) and non-affected subjects (CTRL). For the
first aim we will perform a deep phenotypical characterization of a population of EOPD patients and identify
phenotypical clusters through an unbiased hierarchical cluster analysis. Subjects will also be profiled genetically
through Whole Genome Sequencing (WGS) for the identification of known and new genetic variants, and for
burden analysis of rare gene variants. In the second aim we will assess alpha-synuclein amplification assay, one
of the most promising innovative biomarkers for synucleinopathy, on skin biopsies and CSF of subjects with
EOPD. In the third aim we will characterize the expression profiles of single cells data and an extensive proteomic
panel for inflammatory markers from peripheral blood and cerebrospinal fluid of EOPD, LOPD and CTRL, to
determine inflammatory activation in EOPD and characterize cell-specific (innate vs adaptive immunity).
Finally, we will correlate data from the three aims to assess the profiles of genetics, clinical, inflammatory, and
biomarkers data in EOPD sub-types. While most of the current research on this topic focuses on single aspects
of the disease, this research proposal is innovative because it correlates different disease mechanisms to detect
subtypes of EOPD. The main significance of this project will be to provide new insights in the pathogenesis of
EOPD which will be informative to the design of mechanism-driven therapeutic approaches for EOPD, provide
useful information for patient counseling, and stratify patients for clinical trials.

Public health relevance
NARRATIVE Early Onset Parkinson’s disease refers to a sub-group of patients where the disease starts early in life (before the age of 50 years) and has a profound impact on most of patient’s life and on important productive years. A clear understanding of the pathogenic mechanisms of EOPD is lacking, although this is crucial for the successful design of therapeutic strategies and stratifying patients for clinical trials. The proposed research is relevant to public health because it aims to clarify the contribution of recognized important pathogenic mechanisms of Parkinson’s disease (genetics, inflammation, and alpha-synuclein accumulation) in patient with Early Onset Parkinson’s disease to help patients stratification for clinical counseling and clinical trials.